SUBLINGUAL, INTRAVAGINAL AND INTRAMUSCULAR PROGESTERONE

To compare bioavailability of fixed doses of progesterone given via sublingual, intramuscular or intravaginal routes in an attempt to interconvert dosage regimen when different routes of administration are required.